Design, Development, and Validation of an AI-enabled Legal Planning and Financial Management Training Solution for ADRD Caregivers

PROJECT ABSTRACT
More than 16 million caregivers (‘family members or friends’) of people with Alzheimer’s disease and related
dementias (ADRD) face serious challenges in providing care. ADRD caregivers are frequently tasked with
substantial and overwhelming legal and financial planning, and they face increased financial risk and strain
as a result. Currently, there is no widely available web-based financial and legal training that can be
personalized to meet caregivers’ specific needs. During this Fast Track project, we will begin with a deep
discovery of legal planning and financial management needs of ADRD caregivers, conduct participatory co-
design sessions with diverse caregivers groups, create multimedia training solutions, design an AI-enabled
recommender system to match caregivers with the right training content, and then conduct rolling field trials
with a diverse groups of caregivers to confirm the feasibility, usability, and acceptability of our legal planning
and financial management training solution.
Looking ahead to Phase 3, we expect our solution will support financial stability through delivery of
personalized and actionable training for estate planning and financial management needs. We anticipate a
combination of B2B partnerships and B2C strategies will yield a sustainable revenue model for our caregiver
training solution.

Public health relevance
PROJECT SUMMARY ADRD caregivers face substantial and overwhelming legal and financial planning tasks, which can increase financial strain and emotional stress. During this Fast Track project, we will conduct deep discovery of legal planning and financial management needs of ADRD caregivers and field test an AI-enabled solution. We anticipate our solution approach will support financial stability through delivery of personalized and actionable training, reduce caregiver stress, and potentially improve quality of life within the care partnership.